PROJECT 3: Animal model of sex differences in stress-related cellular function in alcohol use disorder

PROJECT 3 ABSTRACT
The role of Project 3 is to identify and translate the neurobiological mechanisms underlying the ‘dark side
of addiction’ studied across Projects 1 and 2. Problematic alcohol use continues to increase, with stress and
negative emotions playing a particularly influential role in women. Understanding the neural pathways
involved in negative reinforcement drinking (NRD) is therefore a public health priority. We have developed
and validated a paradigm for evaluating NRD in mice in a modified “drinking-in-the-dark” (DiD) protocol. Both
male and female mice escalate ethanol (EtOH) intake and preference over time in this paradigm. In addition,
we have found that exposure to a physical stressor coupled with repeated exposure to the previously stress-
paired environment induces stress-induced binge-drinking in female, but not male, mice. A common
intracellular signaling pathway underlying effects of alcohol, stress and neuroinflammation is the cAMP
pathway. Emerging studies in animal models and human clinical subjects have demonstrated beneficial
effects of blocking cAMP breakdown using the phosphodiesterase 4 inhibitor Apremilast on alcohol intake.
Our preliminary studies in mice show promising results indicating that Apremilast decreases EtOH intake as
well as the stress-induced binge escalation seen in female mice. We propose to determine the effect of PDE4
inhibition on interactions between stress and ethanol intake in male and female mice, to identify downstream
signaling pathways recruited by PDE4 inhibition that regulate alcohol drinking and to determine whether
increasing cAMP signaling through a GLP1 agonist can mimic the effects of PDE4 inhibition in the stress-
induced alcohol drinking paradigm in male and female mice. These studies will support the identification of
pathways important for effects of stress on alcohol-related behaviors, potentially aiding in development of
novel medications and combinations thereof that will be particularly effective in helping women quit drinking.

Public health relevance
PROJECT 3 NARRATIVE Women are more likely to drink in response to stress than men. Project 3 will study molecular mechanisms for sex differences in negative reinforcement drinking to be studied in Projects 1 and 2 to help provide new targets for the treatment of alcohol use disorder. We will contribute to the public health by investigating sex differences in neuronal function and neuroimmune signaling that respond to alcohol and stress, and determine whether these factors can be targeted to develop therapeutics tailored to address the unique vulnerability of women to stress-induced alcohol intake.